EFFICACY OF RHESUS MONKEY AND HUMAN RHESUS REASSORTANT ROTAVIRUS VACCINE

The purpose of this CLINFO study is to assess the reactogenicity and immunogenicity of two different rotavirus vaccines over time, by continued surveillance of immunized children.